HORMONAL, SYMPTOMATIC, AND NEUROPHYSIOLOGIC RESPONSE TO SUGAR INTAKE IN CHILDREN

Children with attention deficit disorder and normal children are being studied to evaluate hormonal, symptomatic and neuropsychologic responses to sugar intake.